Chemical proteomic mapping and functional manipulation of extracellular proteinaceous cysteines

Project Summary
Around 262,000 cysteine residues are intricately distributed throughout the human proteome. These cysteines
play pivotal roles in influencing protein folding, stability, enzymatic functions, and the response to oxidative stress.
Chemical probes designed to target cysteines are critical tools for investigating protein functionality and
advancing drug development. Chemical proteomics, particularly cysteine-directed activity-based protein profiling
(ABPP), has emerged as a fundamental technique for studying proteinaceous cysteines. ABPP employs a wide-
spectrum cysteine-reactive probe to effectively pinpoint cysteine sites across a variety of proteins, enabling
comprehensive functional exploration and facilitating ligand discovery. Traditionally, extracellular proteinaceous
cysteines have been largely neglected in the field of chemical proteomics. It was also believed that these
cysteines mainly formed disulfide bonds to stabilize protein structures. However, recent research has challenged
this notion by revealing the dynamic nature of extracellular redox environments, which can significantly influence
proteinaceous cysteine reactivity in the extracellular space. Consequently, a substantial knowledge gap remains
in identifying extracellular proteins containing unmodified, reactive cysteines in specific biological contexts. To
address this gap, this research program aims to establish an innovative chemical proteomic platform tailored for
mapping extracellular proteinaceous cysteines across a wide range of biological scenarios. These scenarios
include T cell activation, GGT5 genetic knockout, and various chemical treatments. Subsequently, we will
investigate the potential druggability of these extracellular proteinaceous cysteines. Finally, utilizing the insights
gained from targeting druggable extracellular proteinaceous cysteines, we aim to manipulate their functionality
in pursuit of two key outcomes: inducing cell-cell interactions and promoting targeted protein degradation.

Public health relevance
Project Narrative This research program aims to develop a chemical proteomic platform for the investigation of extracellular proteinaceous cysteines. Using this pioneering platform, our goal is to decipher the complex landscape of reactivity among extracellular proteinaceous cysteines and leverage these cysteine sites for functional applications.